Safety-Enhancing Motor Vehicle Child Safety Seat

Project Summary/Abstract
Minnesota HealthSolutions Corporation (MHS) proposes to develop an enhanced child safety seat that offers
improved crash protection and mitigation against misuse. Child safety seats are installed in vehicles by properly
attaching and tensioning the main seat-to-vehicle anchorage points. Proper use of the seat-to-vehicle
attachments is extremely important in achieving the maximum available reduction of child injuries in motor vehicle
crashes. Unfortunately, the attachments are inconveniently located on child safety seats and difficult to use
properly. Several large studies have observed that only 10% to 40% of children are correctly harnessed into
correctly installed seats. Improper use of child safety seats substantially reduces their effectiveness and is a
major public health concern. The proposed child safety seat will offer enhanced crash protection through an
innovative, inexpensive easy-to-use feature that will improve crash performance and also help mitigate the effects
of seat misuse. We hypothesize that the proposed child safety seat will reduce vehicle crash-related child injuries
and deaths. An interdisciplinary team of researchers has been assembled to define, build, and evaluate a
production prototype system.

Public health relevance
Project Narrative Motor vehicle crashes are a leading cause of unintentional morbidity and mortality among children in the United States and a leading cause of brain injury. In the past ten years, thousands of children have died in unintentional crashes and millions more had hospital-treated injuries. We aim to develop an enhanced child safety seat that improves crash protection for children as well as provides protection against seat misuse.